Asthma and Technology in Emerging African American Adults (The ATHENA Project)

Asthma causes substantial morbidity and mortality in the U.S., particularly among African American emerging
adults (AAEA; ages 18-30), but very few asthma programs have targeted this population. Interventions that
provide education and address underlying motivation for managing asthma may be most effective. However,
intensive, face-to-face interventions are often difficult to implement, especially among emerging adults. The
purpose of this proposal is to develop an effective mobile asthma management intervention to improve control
in AAEA. We will assess the ability of multiple technologic components to assist and improve traditional
asthma education: 1) MES. The Motivational Enhancement System (MES) for Asthma Management is a
mobile 4-session intervention utilizing supported self-regulation and Motivational Interviewing (MI).
Personalized content is based on each participant’s activity level, daily experiences, and goals. 2) SA.
Supportive accountability (SA) is administered by asthma nurses utilizing targeted mobile support (Skype/voice
calls) to provide education, promote self-efficacy, and overcome barriers through an MI-based framework. 3)
SMS. Text messaging (SMS) provides reminders for asthma education, medication adherence, and physical
activity. 4) PAT. Physical activity tracking (PAT) uses wearable technology to help meet user-defined physical
activity goals. Using a multiphase optimization strategy (MOST) framework, we will test these 4 intervention
components and combination of components to identify the most effective mobile intervention. MOST is an
innovative, cost- and time-effective framework that utilizes engineering principles to produce effective
behavioral interventions. We will conduct a component selection experiment using a factorial research design
to build an intervention that has been optimized for maximum efficacy. We will use a clinically significant
improvement in asthma control as the criterion for determining which components should be kept in the
optimized intervention. Participants (N=180) will be randomized to 1 of 6 intervention arms consisting of
various combinations of the intervention components. This experimental design is equivalent to conducting
multiple pilot randomized clinical trials to evaluate the efficacy of each component, yet uses only a fraction of
the sample size and resources. At the completion of the study, we will have an empirically-supported,
optimized mobile asthma management intervention to improve asthma control for AAEA. Participants will be
recruited from multiple sites of the American Lung Association Airway Clinical Research Center network and
ambulatory care clinics at the Detroit Medical Center. Data collections will occur at baseline, 3, 6, and 12
months. We hypothesize that post-intervention (3, 6, and 12 months), participants with uncontrolled asthma will
show clinically-significant improvement in asthma control. We hypothesize that improvements in asthma
management behaviors (including physical activity), quality of life, symptoms, adherence, and exacerbations
(secondary outcomes) will also be observed.

Public health relevance
African American emerging adults (ages 18-30) are disproportionately impacted by asthma, but have been under-represented in research. Mobile asthma management interventions may help improve asthma control and allow people to live healthier lives. During this project, we will use an innovative strategy to develop an optimized mobile asthma management intervention using the most effective combination of nurse-delivered asthma education, a smart phone app, and text messaging.